2/2 WIN Ratio Analysis to Determine a Strategy of Non-Invasive SUpport for Respiratory Failure in the EmeRgency Department (WINDSURFER)

PROJECT SUMMARY
We propose the WINDSURFER trial to answer a signature question of emergency care; “What is the
best non-invasive respiratory support (NIRS) strategy for treating acute hypoxemic respiratory failure
(AHRF) in the Emergency Department (ED)?” AHRF is the syndrome of impaired breathing resulting in low
blood oxygen levels, most commonly from lung or other infections, acute decompensated heart failure and
chronic obstructive pulmonary disease. AHRF is a major public health problem as evidenced by its seasonal
and pandemic surges and the >100,000 associated deaths each year in the United States. Aggressive
treatment of AHRF at its earliest stages in the ED is essential to prevent progression to death.
Non-Invasive Respiratory Support (NIRS) is an important and widely used rescue treatment for AHRF that
provides effective high-level breathing support without the pitfalls and consequences of mechanical ventilation.
The two forms of NIRS are: 1) Non-Invasive Positive Pressure Ventilation (NIPPV), which includes continuous
positive airway pressure (CPAP) and bi-level positive airway pressure (BiPAP)], and 2) Heated High-Flow
Nasal Oxygen (HFNO). NIPPV supports breathing by delivering high pressured oxygen through a tight-fitting
face mask. In contrast, HFNO supports breathing by delivering high flows of heated and humidified oxygen
through a specially designed nasal tube. The best NIRS strategy for AHRF is unknown. The optimal
treatment for AHRF must be effective, safe, easy to deploy, comfortable for patients and effective across a
spectrum of diseases and comorbidities.
We propose a new clinical trial, WIN ratio analysis to Determine a strategy of non-invasive SUpport for
Respiratory Failure in the EmeRgency Department (WINDSURFER), to determine the best initial NIRS
strategy for patients presenting to the ED with AHRF. We will execute the trial using EDs selected from the NIH
Strategies to Innovate Emergency Care Clinical Trials Network (SIREN). We will randomize adult ED patients
(n=500) with AHRF to a treatment strategy of 12 hours of NIPPV or HFNO. The primary outcome is the
hierarchical Major Adverse Pulmonary Events (MAPE): 1) hospital mortality, 2) ventilator-free days, and 3)
NIRS hours. We will compare differences in MAPE between NIPPV and HFNO using the Win Ratio, a novel
technique to assess differences in a hierarchical composite outcome. Our aims are:
Aim I: Determine the effectiveness of ED NIRS strategies (NIPPV vs. HFNO) upon AHRF outcomes. We
will test the hypothesis that HFNO is superior to NIPPV, as demonstrated by lower MAPE.
Aim II: Evaluate the safety of ED NIRS strategies (NIPPV vs. HFNO) in AHRF. We will evaluate the risk
differences between NIPPV and HFNO for the development or worsening of three specific safety outcomes: 1)
pneumonia/ pneumonitis, 2) ARDS and 3) shock.

Public health relevance
PROJECT NARRATIVE Resuscitation from critical illness requires skillful delivery of oxygen. This project will compare two Emergency Department strategies for delivering life-saving oxygen to adults with acute respiratory failure. The findings will improve public health by defining the best approaches to improve survival and outcomes of adults with acute respiratory failure.